Florida Department of Agriculture and Consumer Services Implementation of the Animal Feed Regulatory Program Standards

Project Summary Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) RFA-FD-15-021 Florida Department of Agriculture and Consumer Services Division of Agricultural Environmental Services Proposal to FDA for Participation in the Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18)- RFA-FD-15-021 The Florida Department of Agriculture and Consumer Services (FDACS) is requesting funding to enhance the infrastructure and effectiveness of Florida's Feed Safety monitoring and enforcement programs through participation in Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) - RFA-FD-15-021. The Department's Division of Agricultural Environmental Services would be responsible for administering this project. FDA's support of the division would enable the development of a far more comprehensive and responsive feed safety program in Florida. The capacity to rapidly identify feed related problems and incidents, and to determine and coordinate integrated and effective responses, is fundamental to the effective regulation of animal feed and feedstuffs for protection of agricultural animals, pets, and their owners, and is a primary objective of the Department's proposed participation in this project.

Public health relevance
Project Narrative Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) RFA-FD-15-021 Florida Department of Agriculture and Consumer Services Division of Agricultural Environmental Services Proposal to FDA for Participation in the Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18)- RFA-FD-15-021 The Florida Department of Agriculture and Consumer Services (FDACS) is requesting funding to enhance the infrastructure and effectiveness of Florida's Feed Safety monitoring and enforcement programs through participation in Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) - RFA-FD-15-021. The capacity to rapidly identify feed related problems and incidents, and to determine and coordinate integrated and effective responses, is fundamental to the effective regulation of animal feed and feedstuffs for protection of agricultural animals, pets, and their owners, and is a primary objective of the Department's proposed participation in this project. The enforcement component of this project will provide benefits to the State of Florida and the FDA by providing for the uniform enforcement of state and federal feed statutes. This project will also provide improved enforcement capabilities to FDA by extending its enforcement arms to a critical agricultural arena and by providing a stronger regulatory presence. Ultimately, FDACS will be able to create a risk-based feed safety program. The laboratory component will provide benefits to the State of Florida and FDA through increased and more effective feed monitoring using a more technologically advanced and efficient laboratory operation to support additional inspections. This will, in turn, reduce the potential for contaminants in the feed supply. Finally, this partnership will allow FDACS and FDA the full-scale capability to provide comprehensive response to feed safety emergency issues.